Light adaptation in regionally and functionally distinct retinal circuits

PROJECT SUMMARY
Visual tasks, like reading print or recognizing faces, often require detailed spatial information collected under
changing lighting conditions. In the retina, as light intensity varies so do the gain and kinetics of neural
responses—a process called adaptation that prevents saturation and supports a consistent perception of
contrast. A significant gap in knowledge is how light adaptation functions in the fovea—the central most region
of retina responsible for high-acuity vision. Retinal circuit adaptation relies on signal pooling, and therefore
adaptation may vary between foveal and peripheral regions that differ in convergence. Additionally, cone
photoreceptors in peripheral primate retina are known to be asymmetric in their sensitivity to light increments vs
decrements. Therefore, circuit adaptation may differ in ON and OFF visual pathways. The objective of this project
is to use distinct primate retinal circuits—foveal vs peripheral and ON vs OFF—to determine how circuits with
differing signal to noise ratios modulate gain and kinetics across light conditions. Aim 1 will determine the impact
of convergence on properties of retinal circuit adaptation (gain, kinetics, noise, and time course) in the primate
foveal vs peripheral midget and parasol pathways, as well as the contribution of synaptic inhibition as a potential
mechanism for circuit adaptation to luminance. Aim 2 will determine how asymmetries inherited from cone
photoreceptors shape the functional properties of adaptation in the primate ON vs OFF peripheral midget
pathway. Given the importance of the fovea for our everyday vision, this work will bridge a gap in our knowledge
of how foveal circuits adapt to changes in contrast over varying background luminance, critical for the function
of high-acuity vision. These results will positively impact the pursuit towards prosthetic retinal implants that can
recapitulate properties of foveal circuits by providing a template for function in diverse retinal circuits. The training
plan described in this proposal is designed to enable me to develop the skills necessary to reach my career goal
of an independent investigator. By following this plan with the guidance of my sponsor and co-sponsor, I will
continue to learn new electrophysiology techniques to build a strong foundation in retinal circuit research. I will
develop my writing, communication, teaching, mentoring, networking, and scientific outreach skills. This research
will take place at the University of Wisconsin-Madison where the strong intellectual environment and availability
of primate tissue from the Wisconsin National Primate Research Center will be leveraged.

Public health relevance
PROJECT NARRATIVE Disruptions to sensory pathways cause sensory impairment, like hearing or vision loss, that can profoundly impact quality of life. Bypassing nonfunctional or damaged sensory circuits and restoring sensory perception via electrical prostheses has proven remarkably successful for cochlear implants, while retinal prostheses have comparatively lagged behind. Knowledge of basic retinal circuit function, including that in the central most part of the retina—the fovea, responsible for our 20/20 vision—will inform design of prosthetic devices that can better restore sight in blind individuals.